Mentorship in Pulmonary Vascular Disease

Pulmonary arterial hypertension (PAH) is a rare lung disease characterized by progressive pulmonary vascular
obliteration resulting in right ventricular failure and ultimately death. Throughout the last three decades there
has been tremendous progress in understanding disease mechanisms that have led to new therapies, however
survival remains poor at approximately 8 years after diagnosis for most patients. There have been several
recent NIH/NHLBI sponsored workshops on phenotyping patients with PAH and moving accumulating “Omic”
data into the clinic to advance precision medicine in PAH, yet there are few centers in where this work is
ongoing and training the next generation of researchers in these techniques will be critically important to
advancing the field of PAH therapy and pulmonary vascular disease more broadly. Dr. Hemnes is a well-
recognized expert in this field and her objective is to use the support of the K24 Midcareer Investigator Award
in Patient-Oriented Research to focus on training the next generation of scientists to bring precision medicine
approaches to PAH patient therapy. The candidate’s immediate and long-term career objectives are directly in
line with the goals of the NIH K24 award, to provide support for protected time for awardees to devote to
patient-oriented research and culturally-sensitive mentoring for students, residents, fellows and junior faculty.
Specifically, this award will allow her to focus on the development of (1) a patient-oriented research program in
pulmonary vascular disease research and (2) a mentoring program to facilitate the career development of new
investigators. This award will provide protected time for the candidate to devote specifically to developing
mentoring skills in patient-oriented research. Her objective is to recruit and mentor students, residents, fellows
and junior faculty for successful clinical research careers in pulmonary vascular disease and to support the
career advancement of her current trainees who are fellows and junior faculty members. To expand her
patient-oriented research program in PAH, she will combine two lines of study in her research portfolio (1)
understanding how insulin resistance in the lipid axis may predispose to PAH or affect outcomes and (2) using
Omic techniques to deep phenotype patients with pulmonary vascular disease. The proposal here will build on
her funded work to test the hypothesis that Omic signatures in PAH can identify features of resilience to PAH
progression and metabolic intervention susceptibility. The specific aims are (1) To compare PAH patients with
and without Omic signatures of metabolic dysfunction, define differences in clinical and molecular features and
measure relevant outcomes between the two groups, (2) To test and validate Omic predictors of metformin
responses in completed and ongoing clinical trials in PAH patients. Completion of these aims will enhance
understanding of the pathogenesis of PAH and uncover potentially improved treatment strategies of metabolic
disease in PAH specifically. The proposed new research, along with the candidate’s other funded research
projects, will provide invaluable training opportunities in patient-oriented pulmonary vascular disease research.

Public health relevance
This award will provide protected time for Dr. Anna Hemnes to devote specifically to developing mentoring skills in patient-oriented research. Her objective is to recruit and mentor students, residents, fellows and junior faculty for successful clinical research careers in pulmonary vascular disease and to support the career advancement of her current trainees who are fellows and junior faculty members. The proposal here will build on her funded work to test the hypothesis that Omic signatures in PAH can identify features of resilience to PAH progression and metabolic intervention susceptibility.